The role of And-1 in R-loop and endocrine resistance in breast cancer

Project Summary
As one type of endocrine therapy (ET) drugs, aromatase inhibitors (AIs) are the first line of treatment for ER+
breast cancer; however over 20% of patients eventually develop AI resistance during treatment. Changes in the
estrogen receptor 1 (ESR1) gene, including mutations, are one of the major mechanisms contributing to AI
resistance, for which there is currently no treatment. Thus, it is urgent to develop a novel approach to overcome
AI resistance caused by ESR1 mutations. We recently identified an R-loop located at a transcriptional enhancer
of ESR1 that regulates ESR1 expression, providing a novel approach to overcome AI resistance by targeting R-
loop resolution.
And-1 is an HMG box domain-containing protein involving in DNA replication and repair. And-1 is highly
expressed in tumors but not in normal tissues, and is essential for tumor cell growth and proliferation. Multiple
independent studies have identified And-1 as an excellent target gene for cancer therapy. Our preliminary studies
indicated that And-1 is critical for R-loop resolution. Using both high-throughput and in silico drug screens, we
successfully identified potent And-1 inhibitors. The major objectives of this application are to: (1) determine a
novel molecular mechanism by which And-1 promotes R-loop resolution using in vitro and in vivo assays, and
(2) assess the effects of And-1 inhibitors on AI resistance using AI resistant patient-derived xenograft (PDX) and
syngeneic breast cancer models. The completion of proposed studies will not only elucidate a new mechanism
regulating R-loop resolution in ER+ breast cancer, but also provide an innovative therapeutic strategy to treat
AI-resistant breast cancer patients.

Public health relevance
Project Narrative Aromatase inhibitors (AIs) are the first line of treatment for ER+ breast cancer; however over 20% of patients eventually develop AI resistance during treatment. Mutation of the estrogen receptor 1 (ESR1) gene is one of the major mechanisms contributing to AI resistance, for which there is currently no treatment. In this application, we will determine a novel mechanism regulating ESR1 transcription and evaluate effects of potential new drug combinations for treatment of AI-resistant breast cancer.